ROLE OF ANGIOTENSIN IN DIABETIC RENAL DISEASE

This study is designed to compare the effects of angiotensin II (AII) and angiotensin converting enzyme inhibitor on renal hemodynamics (glomerular filtration rate and renal plasma flow) in Type I diabetics with or without elevated Na/Li CTT and parental history of hypertension.